I-CARE 2 RCT: Mobile Telehealth to Reduce Alzheimer's-related Symptoms for Caregivers and Patients

PROJECT SUMMARY/ABSTRACT
Among patients with Alzheimer’s disease and related dementias (ADRD) and their informal caregivers,
behavioral and psychological symptoms of dementia (BPSD) are a critical need requiring scalable, evidence-
based intervention. As many as 97% of patients with ADRD will ultimately experience BPSD, yet they are
poorly managed and remain the top source of caregiver burden. Technology may be a solution; indeed, the
National Institute on Aging and others demand mobile technology-based behavioral interventions to support
informal caregivers of patients with ADRD. Systematic reviews and market analyses of existing mobile
technologies or “apps” demonstrate promise but critical limitations: lack of scientific foundation and evidence of
efficacy; missing features and functions; and low to moderate quality.
Our interdisciplinary team followed the NIH Stage Model for Behavioral Intervention Development to:
1) establish an evidence-based intervention model for BPSD management (NIH Model Stage 0); 2) apply user-
centered design to embed this evidence-based model into Brain CareNotes, a mobile telehealth app (NIH
Model Stage IA); and 3) conduct I-CARE, a set-up pilot study that established the feasibility and potential
efficacy of Brain CareNotes (NIH Model Stage IB-II). The pilot study demonstrated that at the 6-month
endpoint, Brain CareNotes reduced informal caregiver burden and reduced BPSD.
Here we propose I-CARE 2, a Stage III randomized clinical trial (RCT), as the next step in the NIH Stage
Model. I-CARE 2 will evaluate the real-world efficacy of Brain CareNotes on the primary outcomes of informal
caregiver burden and BPSD at 12 months. We plan to enroll N=160 community-dwelling, English-speaking
informal caregivers of patients with ADRD, across the state of Indiana. Informal caregivers will be randomized
(stratified by sex and race) to 12 months of Brain CareNotes (n=80) or Attention Control education-only app
(Dementia Guide Expert) (n=80). Follow-up will occur at 12 months, with additional assessments at 6 months
to test for early effects. We will test primary hypotheses that, relative to Attention Control, informal caregivers
randomized to Brain CareNotes will have: (H1) lower caregiver burden as measured by the Caregiver Distress
sub-score on the Neuropsychiatric Inventory (NPI); and (H2) lower BPSD as measured by the NPI Total Score.
Secondary hypotheses will be tested comparing groups on (H3) depressive symptoms as measured by the
Patient Health Questionnaire (PHQ)-9 and (H4) acute care utilization as determined by the number of hospital
and emergency room visits captured in the statewide regional health information exchange.
If successful, this NIH Stage III RCT study will yield evidence of the efficacy of a highly scalable non-
pharmacological intervention for BPSD, one of the most burdensome aspects of ADRD care. If our caregiver-
facing mobile telehealth app is efficacious in real-world settings, subsequent Stage IV-V effectiveness and
implementation research efforts can help relieve the critical public health burden of ADRD.

Public health relevance
PROJECT NARRATIVE This randomized clinical trial tests how telehealth technology can positively affect informal caregivers and patients living with Alzheimer’s disease and related dementias. The project will gather data over time to measure the impact of our evidence-based Brain CareNotes mobile telehealth app on informal caregiver burden and patients’ behavioral and psychological symptoms of dementia, in a diverse Indiana-wide sample.